Cytogenetics

PROJECT SUMMARY (See instructions): The Cytogenefics Core has been approved as an established Shared Resource of DF/HCC since it's founding. Charies Lee has directed the facility since 2006, after serving as its Assistant Director for six years. Cytogenetic studies can provide insight into regions of the genome that are pathogenetic in various neoplasms leading to an understanding ofthe molecular pathways participating in the biology of cancer. An invaluable function of the Cytogenetics Core is access to consultation for experimental design and data interpretation with the Core Directors. Consultation provides the investigator with guidance and advice regarding the best approach for the goal(s) of a specific study. Services of the Core are primarily focused on human and mouse cytogenetics and include: 1) conventional karyotyping of fissue specimens and cell lines, 2) fluorescence in situ hybridization (FISH) for metaphase and interphase preparations, and 3) comparative genomic hybridization (CGH) on microarrays. Director: Charies Lee, PhD(MWH) Category: 1.15 (Cytogenetics) Management: Joint (Cancer Center and Institutional).

Public health relevance
RELEVANCE (See instrutctions): The mission of the Cytogenetics Core is to provide state-of-the-art cytogenetics services to DF/HCC scientists to facilitate investigations of the pathogenesis and pathobiology of neoplasia. Cytogenetic studies may also be important in establishing a diagnosis for correlation with clinical outcome. Cytogenetics is a fundamental adjunct to a variety of investigations underway, including basic and translational research.